Defining the contributions of proprioception to goal-directed reaching movements

Project Summary
The ability to perform rapid, goal-directed movements accurately and efficiently is critical for interacting with the
environment. These movements have provided a key behavioral paradigm for experimental and clinical study,
helping to establish theories of sensorimotor control and to characterize motor impairments in many neurological
disorders. The accurate execution of rapid, goal-directed movements is enabled by the characteristic, reciprocal
activation of opposing muscles that accelerate and decelerate the limb in a temporally precise manner. Many
sensorimotor disorders across the nervous system (e.g. sensory deafferentation and cerebellar disease) disrupt
this characteristic muscle activation, leading to impaired motor performance. Therefore, the emergence and
disruption of this stereotyped pattern of muscle recruitment offer theoretical and clinical insights into how
sensorimotor circuits enable speed and accuracy. Yet the neural mechanisms that establish and control this
reciprocal muscle recruitment remain elusive, in large part because the relative contribution of proprioceptive
feedback from the muscles has not been clearly established. Although behavioral observations and
computational models have implicated proprioceptive feedback in coordinating limb movements, the direct
causal role of these sensory pathways in driving temporally precise muscle activation in intact, behaving animals
has been difficult to investigate. The challenge is due, in part, to the inability of traditional experimental methods
to perturb specific neural circuits in a temporally precise and reversible manner. To address these issues, this
proposal will combine a computational model of the spinal sensorimotor system with temporally precise, circuit
specific manipulation of the following: a) selective proprioceptive afferent pathways and b) a set of inhibitory
spinal interneurons that modulate the strength of proprioceptive feedback in behaving mice. Specifically, two
Aims will address key outstanding questions: 1) What are the specific proprioceptive feedback pathways that
contribute to stereotyped muscle activation patterns during the acceleration and deceleration phases of limb
movement, and during which phases of movement is proprioceptive feedback required (Aim 1)? 2) How does
temporally precise modulation of feedback strength (gain) by spinal interneurons ensure appropriate muscle
activation patterns (Aim 2)? The overarching hypothesis of this proposal is that the amplitude and timing of
agonist and antagonist muscle activity depend critically on temporally precise tuning of selective proprioceptive
feedback pathways, and disruption of such feedback causes aberrant and inaccurate movements. Answering
these questions will help to uncover the computational logic implemented by sensorimotor pathways for the
accurate and efficient execution of rapid movements and reveal how disruption of these pathways produces
motor deficits. In addition, by defining spinal circuit mechanisms that control limb movement, this work will lay
the groundwork for future studies investigating how descending motor systems recruit spinal circuits to ensure
appropriate muscle activation patterns.

Public health relevance
Project Narrative Fast, accurate movement of the limbs is essential for performing many everyday activities. Disease and injury can often impair the ability to perform such movements, compromising quality of life for those affected. This proposal aims to uncover neural mechanisms responsible for generating fast and accurate movements, laying a foundation for improved diagnosis and treatment of movement disorders.